RAGE/mDia1, Macrophage Trafficking and Inflammation in Regression of Diabetic Atherosclerosis

Summary Cardiovascular disease (CVD) represents the major cause of morbidity and mortality in patients with diabetes. Despite aggressive management of levels of lipids and glucose, both types 1 and 2 diabetic patients exhibit earlier onset and more extensive atherosclerotic lesions than non-diabetic subjects, and the response to lipid- lowering strategies is significantly less robust than the beneficial effects noted in non-diabetic subjects. Preclinical studies in diabetic animals have shown accelerated progression and impaired regression of atherosclerotic plaques, as well as increased retention of macrophages (MØs) in plaques. We will focus on diabetes-driven mechanisms linked to impaired atherosclerosis regression and the specific role of MØ perturbation. Our proposed studies are built on the discovery that transplantation of aortic arches from Ldlr-/- mice into diabetic mice deficient in RAGE or its cytoplasmic domain binding partner, DIAPH1, required for RAGE signaling, display significantly improved plaque regression, independent of changes in plasma glucose or lipid levels, compared to wild-type diabetic mice. Our earlier studies demonstrated that activation of RAGE is a critical component of the vessel wall response to hyperglycemia and that RAGE-driven mechanisms accounted for the observed acceleration and progression of atherosclerosis. In this application, using models of hyperglycemia and insulin resistance (IR), we will test the hypothesis that the consequences of hyperglycemia and RAGE/DIAPH1-dependent mechanisms in MØs modulate MØ trafficking (recruitment & retentions/stasis), MØ inflammatory polarization and MØ metabolism and oxidative stress, mechanisms which converge to suppress regression of established atherosclerotic plaques in diabetes. We will test novel pharmacological antagonists of RAGE/DIAPH1 in our murine model of diabetic atherosclerosis regression. These studies will provide novel insights into diabetes specific mechanisms that promote MØ accumulation and impair regression, and foster the development of novel therapeutic adjuncts for diabetic atherosclerosis.

Public health relevance
Project narrative Cardiovascular disease (CVD) represents the major cause of morbidity and mortality in diabetic subjects and includes cardiac, macrovascular and microvascular diseases. Despite aggressive management of lipids and glucose, clinical studies have shown that both type 1 and type 2 diabetic patients exhibit earlier onset and more extensive atherosclerotic lesions than age-matched, nondiabetic populations, in parallel with impaired regression of diabetic atherosclerosis. There is a need to better understand the hyperglycemia specific mechanisms by which macrophages accumulate and impair plaque regression in diabetic atherosclerosis.